T32 training grant in medical genetics.

T32: Research Training Program for Physician Scientists in Medical Genetics; PDs: Eva Morava and Tamas Kozicz
PROJECT SUMMARY/ABSTRACT
Genetics and genomics are often hailed as revolutionary approaches with the capacity to transform healthcare
across various medical specialties. However, there is a noticeable shortage of physician-scientists specializing in
genetics and genomics, particularly in fields such as medicine, pediatrics, neurology, psychiatry, obstetrics, and
oncology. This shortage underscores the urgent need for physician-scientists who can spearhead research
programs that harness the expanding body of genetic and genomic knowledge. They should also be adept at
translating these insights into novel prevention strategies, advanced medical treatments, and precise therapies.
The Icahn School of Medicine at Mount Sinai (ISMMS) has long been a center of excellence in genetics and
genomic sciences. The Department of Genetics and Genomic Sciences (DoGGS) has successfully administered a
T32 training grant for 15 years, under the leadership of Dr. Robert Desnick. This program has trained numerous
physician-scientists, equipping them with advanced genetic and genomic expertise and setting many of them up
for an independent research career. Building upon this robust foundation and offering exceptional research
opportunities and mentorship in genetics and genomic sciences, the primary aim of this renewed Training
Program proposal is to seamlessly integrate genetics and genomic sciences into medical research and practice.
To achieve this, we will leverage the exceptional academic environment at ISMMS to support the training of
scholars with M.D., M.D./Ph.D., or Ph.D. backgrounds. The program's curriculum emphasizes cross-disciplinary
training to prepare scholars for the present and future challenges of genetics and genomic sciences, which
increasingly require the integration of complementary research skill sets. To meet this demand, we have
assembled a distinguished group of mentors not only from within DoGGS but also from nine clinical
departments, as well as outstanding multi-disciplinary institutes and centers at ISMMS. Over the course of five
years, this program will annually support three scholars (PGY 4 - PGY 6), resulting in a total of 15 candidates.
Our comprehensive training program provides a curriculum that combines blended and self-directed learning
approaches. It effectively incorporates a strong foundation in genetics and genomic sciences, emphasizing
research excellence. Scholars enrolled in this program will be required to allocate a minimum of 80% of their
efforts toward fundamental, translational, and/or clinical research endeavors. To ensure their progress, regular
quarterly meetings will be conducted with their advisory committee and program directors. This training
program, rooted in a successful legacy of training physician-scientists at DoGGS, is dedicated to achieving
excellence. It leverages the institution's robust scientific environment and boasts an exceptional faculty, all of
which are instrumental in nurturing the next generation of leaders in investigative genetics and genomic
sciences.
PROJECT SUMMARY/ABSTRACT

Public health relevance
T32: Research Training Program for Physician Scientists in Medical Genetics; PDs: Eva Morava and Tamas Kozicz PROJECT NARRATIVE We aim to increase the number of physicians aspiring to pursue a research-focused career by securing time and mentorship needed to acquire scientific competence, while practicing both science and medicine, in a supporting mentored environment together with like-minded peers. Our proposal involves creating a comprehensive postdoctoral research training initiative in investigative genetics and genomics with the program objective to nurture the forthcoming cohort of autonomous scholars by offering tailored, self-directed educational and research initiatives with personalized mentorship. These initiatives will empower scholars to address the existing gaps in genetic and genomic medicine, enabling them to forge their independent scientific research careers. PROJECT NARRATIVE